Basic neural processing mechanisms of live human face viewing

Project Summary
Significance. The human brain has a dedicated neural system for processing other humans. However relatively
little is known about the basic mechanisms of this processing. Prior research has found that live human face
viewing results in more activity in the right temporoparietal junction (TPJ) than does viewing a face simulation
like a robot face. This suggests that live faces have characteristics that transcend appearance, motion, co-
presence, and embodiment which give them access to sociocognitive systems that face simulations cannot
access. Research question. What are the neural mechanisms of this access and how do they relate to stimulus
acquisition? Further, how might these mechanisms contribute to dysfunction in psychiatric illnesses like
schizophrenia? Addressing these gaps in the literature requires skills in: (1) multimodal data acquisition; (2)
advanced analytics; and (3) experimental design for clinical populations. To pursue these questions long-term
by becoming an independent researcher, I propose a two-phase training plan. In Aim 1, I will supplement existing
skills for multimodal experimental design, acquisition, and preprocessing with intermediate multimodal analytics,
advanced programming, dataset management, and professionalization. Approach. I will do this with a study on
neurotypical neural processing during live human face viewing with robot face viewing as control and will acquire
simultaneous functional Near Infra-Red Spectroscopy (fNIRS), electroencephalography (EEG), eye-tracking,
and pupillometry. I will then apply eye-behavior-guided time frequency decomposition of EGG data, cross-
frequency phase-amplitude coupling, and fNIRS-constrained EEG source localization. Hypotheses. Visual
sensing is an active component of the neural processing of live faces. If true, then we hypothesize that eye
movements and pupil size during live face viewing will be greater due to increased attention and arousal and
greater acquisition of meaningful information from a live face. These differences are hypothesized to correspond
to increased power in gamma (30-100hz)—reflecting configural processing—and theta (4-8hz)—reflecting
perceptual binding. These frequencies are hypothesized to be coupled to each other—reflecting information
transfer from local to global processing—and to localize to regions identified with fNIRS contrasts of live face
and robot face viewing. This will identify the temporal and spatial features of the social processing network.
Preliminary Results. Participants show greater pupil size and differences in dwell time during live face viewing.
Right-TPJ-localized theta band power is greater during live face than robot face viewing. Aim 2, I will complete
post-doctoral training on experimental design for those with schizophrenia and on advanced computational
analytics like factor analysis and predictive coding. I will do this through research on live face viewing paradigms,
such as emotional expression or direct gaze perception, during multimodal data acquisition with a population of
patients and non-patients. This training will give me the skills necessary for long term research independence
to explore the role of social neurocognitive function and dysfunction in health and psychiatric illness.

Public health relevance
Project Narrative Despite the importance of social functioning to both health and psychiatric illness, relatively little is known about the neural processing mechanisms of live human face viewing. While activity in the right temporoparietal junction has been shown to distinguish live face viewing from humanoid robot face viewing, the neural features of that activity and their correlates in stimulus acquisition remain to be seen. This proposal will use simultaneous functional Near Infrared Spectroscopy, electroencephalography, eye-tracking, and pupillometry during live face and robot face viewing to test the hypothesis that visual sensing strategy is an active contributor to the neural processing of live human faces.